GENE THERAPY RESOURCE PROGRAM (GTRP) - CLINICAL COORDINATING CENTER: TASK AREA A - CORE ADMINISTRATIVE ACTIVITIES

The Clinical Coordinating Center for the Gene Therapy Resource Program (GTRP) oversees and coordinates the logistics of the program. They manage the process for requesting services, provide regulatory support to investigators, and other allowable services as requested.